Personalized Digital Behavior Change Interventions to Promote Oral Health

Although preventable, dental disease is one of the most common chronic diseases in the United States
and exacts a substantial personal and societal toll. It is closely linked to low oral health literacy and poor oral
hygiene behaviors (OHBs). Using the high prevalence and burden of dental disease as a proxy, there is a large
gap between knowledge about quality oral hygiene routines and what is practiced by individuals. The causes
are many but ultimately distill down to a systemic failure to communicate oral hygiene instructions (OHIs)
effectively or to engage and motivate patients in their own oral self-care.
To address the know-do gap, we begin by distilling desired brushing behaviors into a simple 2x2x4 OHI
(brushing 2 times a day, for 2 minutes each time, all 4 dental quadrants). We will leverage tracking capabilities
of our innovative eBrush platform to remotely monitor tooth-brushing activities in home settings. Using the 2x2x4
OHI and eBrush as foundational elements, we will develop and evaluate the effectiveness of personalized Digital
Oral Health Interventions (DOHI) for promoting ideal OHBs in at-risk individuals. In the UG3 phase, we will build
out the technologic infrastructure for collecting brushing data and delivering the DOHI. Then, we will engage
target end-users in the co-design of an app for oral self-care and establish the usability and feasibility of the
system. In the UH3 phase, we will build and validate computational models to infer the quality of OHBs from
brushing data and personalize the DOHI. Using a cohort of 130, we will conduct a 10-week Micro-Randomized
Trial to optimize the adaptive tailoring of engagement strategies. Finally, we will evaluate effectiveness of the
computationally-driven, adaptive DOHI in promoting sustained engagement in the 2x2x4 OHB. We hypothesize
that a dynamic and personalized DOHI will be more effective than traditional, static, clinician-delivered OHI in
improving oral health and adherence to 2x2x4 OHBs. We will test our hypothesis through a 6-month, pragmatic,
randomized, controlled, parallel-group clinical trial. Eligible adults from safety-net dental clinics will be equipped
with an electronic toothbrush and the smartphone app for tracking brushing data. After a run-in period (4 weeks)
to ensure technical proficiency and establish baseline OHBs, 260 at-risk subjects will receive a clinician-delivered
2x2x4 OHI and randomized to either: (a) an intervention arm where subjects receive ongoing, personalized
DOHIs at opportune times; or (b) a control arm where subjects lack such feedback. Subjects will be followed for
20 weeks. Trained dental examiners will conduct assessments at each visit (baseline, randomization and after
20 weeks). Primary outcomes are changes in dental health from baseline (Modified Gingival Index and Plaque
Index). Secondary outcome is the quality of adherence to the 2x2x4 OHI. We will explore subject-level features
that predict the magnitude of response to the DOHI. Our team science approach presents a potentially paradigm
shifting opportunity to leverage the growing ubiquity and reach of digital technologies to activate, educate, and
engage patients in optimal oral health self-care in ways and at a scale previously unimaginable.

Public health relevance
3c. Project Narrative Dental disease is caused primarily by poor oral hygiene behaviors. Our research will contribute to the development of technology-assisted behavioral interventions that use electronic toothbrushes and mobile phone apps to provide individuals with personalized feedback on their brushing behaviors and eventually, improve oral health and decrease dental disease.